DMS/NIGMS 1: Modeling Microbial Community Response to Invasion: A Multi-Omics and Multifacton

Most microorganisms live in communities containing hundreds or thousands of species, each engaging
in a rich web of interactions. The complexity of these interactions makes quantitative predictions about
community dynamics difficult. To overcome this, simple proxies for natural communities, designated
"model microbial communities," have been designed to support laboratory study. These models are
complex enough to exhibit community-specific phenomena but simple enough to reveal governing
principles of community interaction. Invasions are among the most destabilizing events that a microbial
community can experience, often resulting in community dysfunction or host disease. We propose to use
THOR, a model community that we developed, to characterize the response to invasion by Pseudomonas
aeruginosa. We will track population dynamics functionally profile molecular interactions.
The multi-omics and multifactorial nature of this study present multifaceted opportunities for statistical
innovation. A truly integrative analysis cannot simply perform parallel hypothesis tests across assays, and
there is a need for a differential testing framework that blends data sources into a unified molecular
interaction network. We will draw from advances in selective inference and multi-omics network analysis to
develop methods that illuminate the molecular interactions driving community response. This will allow us
to tailor interventions that shape dynamics in the THOR model microbial community. We propose:
1. Aim 1: Functionally profile THOR's community response to P. aeruginosa using metabolomics,
metatranscriptomics, and 16S rRNA sequencing and establish associated data curation workflows. These
are the core data-generating experiments and quality control steps that provide accurate and
complementary views of THOR under invasion.
2. Aim 2: Develop differential testing methods that are sensitive to interaction effects and that control
module-level false discovery rates. We will introduce methods for selective inference of differential
interactome modules, like activated biosynthetic pathways.
3. Aim 3: Consolidate software for differential interactome analysis and experimentally validate knockout
targets. These experiments will illustrate a data-driven approach to control invasion dynamics, and our
software will make such analysis easily accessible.

Public health relevance
We will develop tools for interactome analysis in microbial communities with the long-run goal of defining principles behind community behavior and responses to invasion. This project will generate a multi-omics map of the THOR community's response to invasion and concepts that support inference of pathways underlying emergent phenotypes. This will establish the foundation for reasoning about community interactions, a prerequisite for engineering microbial systems for human and environmental health.